COCA: Pilot Core C

PROJECT SUMMARY – Core C
Pilot Core C will oversee the execution and development of pilot projects that bring new
technologies and new investigators into the Center for Cocaine and Opioid Addiction (COCA).
MUSC neuroscience has undergone dramatic growth within the last 5 years that has expanded
the pool of young, talented investigators in preclinical and clincal arenas. The Pilot Core will
provide an opportunity to mentor some of these young investigators into the field of addiction
under the supervision of senior COCA investigators. Both preclinical and clinical pilot projects
will be solicited by advertisement and competitvely reviewed by the COCA Internal Advisory
Board. Once funded, the progress of projects will undergo extensive monitoring by the Core C
Directors and the Internal Advisory Board (IAB). The proposed pilot grants will be evaluated and
prioritized to promote early stage or early established investigators whose work synergizes with
the overall COCA mission. Each pilot awardee will work closely with a senior mentor and report
their progress regularly to the IAB. To illustrate the potential of the Pilot Core to assist in the
development of young investigators and to promote cutting edge preclinical and clinical
research, the proposal outlines four possible pilot projects that, if formally submitted in a call for
pilot grants, will be considered in a competitive manner if the COCA is funded.